Improving outcomes for patients with SDB and insufficient sleep

Sleepiness is a common presenting complaint in sleep centers, and sleep disordered breathing is a common
cause; however, insufficient sleep occurs in over one third of US adults, but is not often addressed. This
proposal is based on the premise that insufficient sleep contributes to sleepiness in patients with SDB, and
may account for the variability in response to PAP therapy in patients with sleepiness and mild SDB. The
objective is to determine the treatment that results in the greatest benefit to patients. We will also explore
differences in blood pressure (BP outcomes) in those with hypertension. We will address the following Specific
Aims: Specific Aim 1: demonstrate the effectiveness of a cognitive-behavioral sleep-time extension (STE)
program compared to PAP in increasing objective alertness. Primary hypothesis 1 is that STE will be non-
inferior to PAP therapy in increasing objective alertness [number of psychomotor vigilance testing (PVT)
lapses]. If signs of superiority of STE over PAP are observed, we will test the Secondary Hypothesis that STE
is superior to PAP in increasing objective alertness among patients with mild SDB. Specific Aim 2: To
demonstrate the effectiveness of STE compared to PAP in reducing daytime sleepiness and fatigue. Primary
Hypothesis 2 is that STE will be non-inferior to PAP therapy in reducing daytime sleepiness and fatigue. If
signs of superiority of STE over PAP are observed, we will test the Secondary Hypothesis that STE will be
superior to PAP in reducing daytime sleepiness and fatigue among patients with mild SDB. We also propose
Exploratory Aim 3: To evaluate the effectiveness of STE compared to PAP in improving endothelial function
and reducing blood pressure among the subset of patients with hypertension. Exploratory Hypothesis 3A is
that, among patients hypertension, STE will be non-inferior to PAP in reducing blood pressure, and Exploratory
Hypothesis 3B is that, among patients with hypertension, STE will be non-inferior to PAP in improving
endothelial function. If signs of superiority of STE over PAP are observed, we will then we will test the
superiority of STE to PAP in improving endothelial function and reducing blood pressure. We will address
these aims by comparing the 4-session STE program to PAP therapy (with a 4-session PAP adherence
program). We will also include a 4-session non-directive equal attention sleep education “control” (SEC)
program. The STE program includes behavioral, cognitive and motivation enhancement strategies to increase
sleep duration. Key outcomes will be measured pre- and post-treatment (1 month) and again at 3-months
follow-up. Results will have significant impact regardless of the findings. If STE is superior to PAP in improving
outcomes, patients with mild SDB should first be encouraged to obtain adequate sleep prior to initiation of
PAP. If STE is non-inferior, either treatment may be viable, and can be based on patient preference.
Conversely, superiority of PAP means a substantial emphasis on troubleshooting and enhancing acceptance
and adherence is warranted.

Public health relevance
Improving outcomes for patients with sleep disordered breathing (SDB) remains an elusive goal despite the use of positive pressure therapy, and we hypothesize that short sleep duration is a key limitation of existing studies since insufficient sleep is a national epidemic. The proposed study will advance understanding of the relative contribution of mild SDB and insufficient sleep as they relate to daytime symptoms by testing two interventions with a 3-group trial design in which we compare a 4-session cognitive-behavioral sleep time extension program to positive airway pressure therapy (PAP) and to a control educational intervention. Key outcomes will be measured before and after treatment (1 month) and again at 3-months follow-up (main outcome time point), and the results of this study will have significant clinical implications, regardless of the findings, by informing future patient-centered studies and interventions.